Strong Families Start at Home/Familias Fuertes Comienzan en Casa: A novel Video and Motivational Interviewing Intervention to improve diet quality of low-income, ethnically diverse children

The diets of US children are suboptimal and effective primary prevention interventions are
urgently needed to shape dietary behaviors early in life, especially among Latinx families, who
experience higher prevalence of obesity and cardiovascular disease. The community energy
balance framework suggests the need to intervene at multiple levels, while addressing cultural
and contextual factors, to effectively impact diet quality for disease prevention including: 1) Child
level, including appetitive traits (satiety responsiveness (sensitivity to internal satiety signals),
food responsiveness (sensitivity to external food cues), and food fussiness; 2) Parent level
including the food parenting practices they use to feed children; 3) Home level including the
availability and accessibility of food, and; 4) Broader context including social determinants, food
security/access to healthy foods. While there have been several interventions aimed at
improving the diet quality of young children, few have targeted more than one of these levels
and almost none are tailored to a child’s appetitive traits, culturally appropriate, and convenient
for busy, working Latinx families. Further, most have only focused on what parents should not
be doing, rather than supporting what they should be doing. This proposal will build on our
recently completed R34 pilot feasibility trial (R34HL140229-01A1) to test the efficacy of a novel
home-based intervention with 257 Latinx families of preschool children. The proposed 6-month
intervention will include: 1) Three home visits by a community health worker (CHW) trained in
brief motivational interviewing that include in-home cooking demonstrations to prepare a meal
involving the child; using a family meal-time video to provide feedback on food parenting; 2)
Screening for social-determinants of health and connecting families to federal/state/local
resources; 3)Text-messages (2x/wk); 4) Tailored materials/messages; and 5) Three CHW
phone calls to reinforce food parenting, food resource management and healthy eating.
Specific Aims are to: Improve quality of the dietary intakes of 2–5-year-old children (Aim 1);
Improve food parenting practices (Aim 2); and Improve the home availability of healthy foods
(Aim 3). Exploratory aims will assess: the relationship between outcome measures and
intervention dose; the relationship between outcome measures and potential mediators and
moderators and the intervention’s effect on child BMI. This study fills an important research gap
by targeting the home food environment with positive food parenting while acknowledging a
child’s appetitive traits. It also meets the NIH call for needed research to reduce health
disparities among Latinx populations and has the potential for high public health impact.

Public health relevance
PUBLIC HEALTH RELEVANCE US children, especially low-income and Latinx, eat too little fruits and vegetables and whole grains, and too many energy-dense snacks and beverages, dietary behaviors associated with increased morbidity from cardiovascular diseases. The proposed research will build upon prior pilot work to test the efficacy of a novel home-based intervention to improve the diet quality and family food environment of preschool age, low-income, Latinx children. The intervention will target healthy food access, engage parents with video-clips of their own meal time behaviors together with motivational interviewing, in-home cooking demonstrations, and tailored materials based on their child’s appetitive traits.